Cancer Research Training & Education Coordination

PROJECT SUMMARY
CANCER RESEARCH TRAINING & EDUCATION COORDINATION
Cancer Research Training & Education Coordination (CRTEC) at Moffitt Cancer Center (Moffitt) comprises 30+
distinct research education and training opportunities that engaged more than 5,700 research, clinical, and
oncology health professional students, trainees, and faculty since 2016. These activities highly impact each of
the five research Programs and span the education continuum, from primary school students to faculty, and
throughout all scientific disciplines. CRTEC’s overarching goal is to foster the best talent in a diverse pipeline of
cancer researchers and oncology professionals. Strategic focus areas are developing advanced support for
fellowship and training grant submissions, enhancing diverse recruitment at all career stages, expanding
educational integration in the catchment area, and supporting new initiatives through four Specific Aims:
Aim 1: To coordinate educational operations and multi-institutional collaborations.
Aim 2: To expand the tracking of all trainees and education activities.
Aim 3: To facilitate career mentorship and career development activities that enable trainees and faculty to
maximize their career potential.
Aim 4: To expand diversity and health equity in the career development pipeline through internal and external
education, peer networking, and proactive recruitment.
CRTEC is a key area of the Research Strategic Plan, evidenced by consolidation of the educational structure
into two integrated offices, Research Education & Training (RET) and Office of Clinical Education (OCE), under
the ACD of Research Education & Training. Together, the RET/OCE offices coordinate all educational activities
of the Center, facilitating the integration and synergy of education. The Center provides over $14 million annually
to support CRTEC efforts. Peer-reviewed funding for training grants increased the from $2.0M last cycle $2.4M
including 3 NCI T32, 1 F, 6 K, and 2 R25 awards. A majority of K-12 and undergraduate trainees are from the
catchment area with 47% from underrepresented populations, while PhD trainees, fellows, and faculty are from
around the world. Former trainees are now leaders in cancer research and clinical care, including 29 faculty who
matriculated from our T32, K, and PhD programs. We also established three novel PhD majors (Cancer
Immunology & Immunotherapy, Cancer Chemical Biology, Integrated Mathematical Oncology), enhanced fellow
training, created an Instructor level to advance senior fellows into faculty, doubled our K grant portfolio, and
established strong mentoring programs for all junior faculty. Finally, integrated efforts with the Community
Outreach, Engagement and Equity Office has further expanded our activities into the community, by providing
STEM exposure to children, parents, and teachers.